EMERGENCY DEPARTMENT UTILIZATION BY INFANTS LESS THAN THREE MONTHS OF AGE

The aim of this project is to determine whether differences exist in emergency department utilization between infants enrolled in fee-for-service Medicaid and Medicaid managed care.